Macrophage identity as a function of cell of origin

PROJECT SUMMARY
Macrophages exhibit remarkable functional heterogeneity and plasticity, reflecting their diverse developmental
origins from yolk sac, fetal liver progenitors, or bone marrow. This diversity underpins their roles in tissue
homeostasis and inflammation, with tissue-resident macrophages, primarily derived from yolk sac and fetal liver
progenitors, involved in homeostatic tasks, and monocyte-derived macrophages from bone marrow driving acute
inflammatory responses. Dysfunctions in these macrophage subtypes are linked to varying disease phenotypes,
such as atopic dermatitis, graft vs host disease, arthritis, atherosclerosis, and Langerhans cell histiocytosis. The
proposed research seeks to delineate the influence of ontogeny on macrophage specification and exploit this
understanding to target dysregulated subsets in diseases like atopic dermatitis, Langerhans cell histiocytosis,
and graft-vs-host disease. Building on preliminary findings that suggest distinct properties and developmental
pathways for macrophages from fetal or adult hematopoietic stem and progenitor cells (HSPCs), and the
identification of AHR as a key gene regulating TRM self-renewal, the study aims to selectively target and
modulate these macrophage subsets. The approach encompasses culture-based methods, xenotransplantation,
and genomic techniques, striving to unveil novel insights and therapeutic strategies for conditions driven by
macrophage dysregulation.
Dr. Katie Frenis is a 2nd year postdoctoral fellow who aims for a faculty position in the next 2 years. The work
above is the cornerstone of the laboratory she hopes to build. Dr. Frenis is interested in the innate immune
system, its heterogeneity, how the heterogeneity arises, and how it impacts disease across the age spectrum.
She has a strong mentorship and collaborative network and aims to learn lab and budget management,
grantsmanship, and administrative details before the R00 phase from her close mentors. Because of her career
in teaching and publishing, she has extensive leadership and teaching/training experience and aims to leverage
that into becoming a dedicated mentor. She will carry out her postdoctoral phase at the hematology/oncology
department at Boston Children’s Hospital, which is a rich environment with a good atmosphere and a proven
track record of producing faculty appointees.

Public health relevance
PROJECT NARRATIVE Macrophages are key players in nearly every inflammatory disease but there is still limited understanding of their behavior and origin in a human context. We aim to understand the role of macrophage subsets, what makes them distinct, and harness this understanding to develop targeting strategies for drug delivery. By hijacking macrophage polarization, we can potentially turn these cells into “sleeper agents” in an inflammatory lesion, which could present an alternative and customizable treatment for uncontrolled inflammation.